Targeting CNS Neuroinflammation in Traumatic Brain Injury by Nasal Anti-CD3

PROJECT SUMMARY / ABSTRACT
Traumatic brain injury (TBI) is a major health problem; 2.5 million Americans sustain TBI each year at a cost of
80 billion dollars annually. Few therapies reduce long-term cognitive sequelae of TBI, and there are only
limited options for rehabilitation. Brain injury causes a primary structural injury followed by a secondary phase,
which involves the activation of the innate and adaptive immune systems. Neuroinflammation with microglia’s
involvement has been identified as a major contributor to the pathogenesis of TBI. However, there is still no
effective immune therapy to modulate the microglial response post-injury. Nasal administration of anti-CD3
monoclonal antibody induces an anti-inflammatory immune response that down-regulates microglial activation
in animal models of multiple sclerosis. The mechanism involves localization of nasal anti-CD3 to cervical lymph
nodes where it induces IL-10-secreting (CD4+LAP+ and CD4+FoxP3+) regulatory T cells (Tregs) that migrate
to the brain and inhibit microglial activation. Nasal anti-CD3 therapy is an unexplored area in TBI, and the
mechanisms by which Tregs modulate microglia in TBI are largely unknown. Dr. Saef Izzy, a trained
neurointensivist with a background in acute brain injury research, hypothesized that nasal anti-CD3 represents
a unique, clinically applicable immunomodulatory approach for the treatment of TBI. Dr. Izzy worked closely
with his primary mentor, Dr. Howard Weiner, to investigate the effects of nasal anti-CD3 on TBI outcomes in
mice. His preliminary data showed that nasal anti-CD3 increases CD4+Tregs and IL 10 expression and
reduces microglial activation in the brain 7 days after controlled cortical impact injury (CCI). It also improves
behavioral outcomes at 1-month post-injury. In this K08 proposal, Dr. Izzy will determine the effects of nasal
anti-CD3 on long-term histopathological and behavioral outcomes after CCI (Aim 1). He will survey the
microglial, effector, and regulatory T cell responses after injury and study the effects of Tregs on microglial
inflammatory response in vitro after CCI (Aim 2). He will investigate the effect of nasal anti-CD3 on IL-10/IL-
10R signaling in microglia using a C57BL6/J mouse harboring IL-10Rflox/floxTMEM119CreETR2, which does not
express the IL-10 receptor on microglia after tamoxifen administration. He will also delineate the role(s) of
other anti-inflammatory cytokines produced by Tregs by neutralizing TGF-β and IL-4 in vitro and in vivo and
study their effects on behavior and microglial inflammatory response post-CCI (Aim 3). Dr. Izzy's career goal is
to better understand how the adaptive immune response interfaces with the innate immune system after TBI.
Successful completion of this proposal will provide insight into the mechanisms by which Tregs modulate the
microglial response after TBI and the identification of novel immune-based therapeutics to improve patients’
outcomes. The proposed K08 application leverages Dr. Izzy’s mentor’s expertise in immunology, mouse
models of acute brain injury, and bioinformatics to provide him with the additional knowledge and experience
necessary to become an independent NIH-funded investigator and expert in the neuroimmunology of TBI.

Public health relevance
PROJECT NARRATIVE In traumatic brain injury (TBI), persistent neuroinflammation contributes to disease progression and poor outcome, and microglia plays a critical role in the neuroinflammatory response following injury. We have discovered a mechanism to decrease the inflammatory nature of microglia, so they are more protective rather than disease-inducing by the nasal administration of anti-CD3 that stimulates immune cells to travel to the brain and decreases inflammation. This work seeks to test this treatment in animal models of TBI to determine its effect on the brain and immune system over time and potentially generate novel therapeutic options for the millions of Americans with TBI.